Role of GDF15 in the Regulation of Host Tolerance to Inflammation

PROJECT SUMMARY
Growth and Differentiation Factor 15 (GDF15) is highly induced in virtually all inflammatory conditions in
humans, including sepsis, cancer and autoimmunity, but its role in the inflammatory response has been
unclear. This proposal seeks to understand the role of Growth and Differentiation Factor 15 (GDF15) in
mediating protection in sepsis.
Preliminary data for this proposal reveals that GDF15 is induced specifically in models of acute
infection/inflammation but not other environmental stress conditions and achieves nanogram levels in
circulation. The GDF15 receptor, glial cell-lone derived neurotrophic factor receptor alpha-like (GFRAL), was
found only in the hindbrain and not induced by inflammation. Blockade of GDF15 led to enhanced mortality in
multiple models of sepsis, including lipopolysaccharide (LPS), cecal-ligation puncture (CLP), Poly(I:C), and
influenza. Conversely, late administration of recombinant GDF15 led to protection. GDF15 inhibition did not
affect inflammatory magnitude or pathogen control. However, GDF15 blockade led to an impairment in the
ability of mice to switch to an oxidative phosphorylation state. There was no difference in ketonemia or plasma
free fatty acids but a significant decrease in circulating plasma triglycerides. We also found that blockade of
GDF15 led to enhanced cardiotoxicity, without a difference in overall hemodynamic control. Thus, GDF15 is a
tissue protective hormone. This proposal seeks to test the idea that GDF15 is an adaptive cytokine produced
by macrophages in response to acute inflammation, which mediates cardioprotection by controlling triglyceride
metabolism via sympathetic innervation.

Public health relevance
PROJECT NARRATIVE Tissue damage and subsequent organ failure in sepsis, such as septic cardiomyopathy, is mediated by inflammatory damage and is the cause of mortality and morbidity. We found that GDF15 plays a role in surviving sepsis by organizing organismal metabolic state thereby maintaining tissue tolerance to inflammation. Identifying pathways that can enhance protective tissue responses to inflammation will contribute to therapeutics that can prevent organ dysfunction and improve survival.